Studying the Molecular Regulation of MGE Projection Neuron Identity by St18

PROJECT SUMMARY: The medial ganglionic eminence (MGE) is a neural progenitor domain located in the ventral
telencephalon. It is well-studied for its production of cortical interneurons, a broadly distributed population of locally-pro-
jecting neurons that regulate cortical rhythmicity. The MGE also produces projection neurons that remain in the ventral
forebrain, arranged in discrete nuclei that project distally point-to-point. Interneuron and projection neuron identity represent
two fundamentally-distinct populations, with distinct functions. How the MGE delineates between the production of IN and
PN, however, is not understood.
We have identified a transcription factor, St18 that appears to regulate this fundamental delineation. We previously
described a model system to study MGE development using induced expression of candidate factors. When St18 was intro-
duced in this system, the cells largely adopted a projection neuron identity. Further, when these cells were transplanted in
utero, they remained in the ventral forebrain and adopted long-range axonal projections reminiscent of globus pallidus pars
externa (GPe). Moreover, in our initial analysis of the St18 conditional loss-of-function mutant mouse, we observed a spe-
cific loss of GPe neurons, while all other MGE lineages appear spared.
In this proposal, we will; Aim 1) Determine whether St18 induced expression is sufficient to direct MGE progenitors
towards projection neuron identity (Techniques: ESC directed differentiation, neuronal culture, in vitro migration assays,
UBM transplantation, RNA-seq). Aim 2) Test whether St18 is necessary for MGE projection neuron fate by analysis of
St18 conditional loss-of-function mouse (Techniques: mouse genetics, viral and dye tracing of axon projections, scRNA-
seq). Aim 3) Manipulate St18 during MGE progenitor differentiation to probe the time window of its action and test how it
regulates gene expression in directing projection neuron identity (Techniques: ESC directed differentiation, in vitro mor-
phology and migration assays, ChIP-seq). Importantly, in the course of our study, we will perform a multi-level expression
and ChIP-seq analysis to uncover the gene networks and cellular pathways under the regulation of St18 that collectively
govern aspects of projection neuron identity: neuronal migration, polarity, process morphogenesis. In summary, we are
uniquely positioned to address how MGE progenitors regulate projection neuron versus interneuron identity in the MGE
lineage. Through these efforts, we aim to inform more broadly as to how projection and interneuron identity is assigned
throughout the nervous system.

Public health relevance
PROJECT NARRATIVE: The medial ganglionic eminence (MGE) is a progenitor domain in the ventral telencephalon that generates both locally-projecting interneurons and long-distance projecting projection neurons; how this delineation occurs is currently unknown. We have identified a transcription factor, St18 that strongly biases MGE progenitors to pro- jection neuron identity. We will examine how St18 does so in gain- and loss-of-function studies as well as at the molecular level.